NANOPHOTOSENSITIZERS FOR REGENERATIVE PHOTOTHERAPY

ABSTRACT
The excitement about nanomedicine stems from the potential application of nanoscience to solve
challenging medical problems. Inorganic nanoparticles (iNPs) exhibit unique properties that favor their diverse
application in medicine, engineering, science, and technology. The large surface-to-volume ratio of these iNPs
provides sites for the attachment of multiple drugs or imaging agents for therapy and imaging of diverse human
diseases. Further conjugation of biological entities, such as proteins, nucleic acids, and lipids, confers specific
targeting of these iNPs to desired tissues in vivo. Recent studies have shown that the intrinsic properties of some
iNPs can be harnessed for therapeutic outcomes. Still, spontaneous stimulation of intrinsic therapeutic effects
through interactions of the NPs with intracellular organelles, proteins, or molecular processes is difficult to
control, leading to significant off-target toxicity. An alternative therapeutic approach is to transform some iNPs
into nanoscale energy transducers. Quantum dots, upconversion NPs, carbon nanomaterials, and photocatalytic
NPs are some nanoscale energy transducers that have shown promise in the treatment of human diseases. The
excellent redox properties of these nanophotosensitizers offer high spatiotemporal control and precision
phototherapy upon absorption of light. Two major limitations of current phototherapeutic interventions are the
limited penetration of light used to activate the photosensitizers, which confines therapy to shallow lesions, and
the frequent reliance on molecular oxygen to generate cytotoxic reactive oxygen species, a condition that
precludes the effective treatment under the hypoxic conditions found in many solid and hematologic tumors.
Recently, we developed radionuclide stimulated therapy that leverages the interaction of Cerenkov radiation
emitting radionuclides to stimulate the production of reactive oxygen species from photosensitizers. The
spatiotemporal therapeutic effects of these interactions allow the treatment of diverse diseases without tissue
depth limitation that affects light-based therapies. Supported by new concepts grounded in robust preliminary
data, we propose to (1) explore new nanostrategies to overcome the impediment to delivering NPs to tumors,
(2) disrupt the protective interactions of cancer with stromal cells to enhance treatment response, and (3) exert
sustainable therapeutic effect via multidimensional combination therapy to achieve disease-free survival.
At the completion of this study, we would develop new nanoplatforms for the treatment and imaging of cancer
and bone lesions.

Public health relevance
Narrative We will develop an oxygen- and tissue depth-independent nano-phototherapy platform using nanophotosensitizers to treat cancer and bone lesions. The research will include a method to deliver enormous amounts of nanoparticles to tumors, destroy cells that support cancer cells, and explore if combined eradication of cancer and supporting cells will improve treatment outcome.